Development of Mouse Models to Study the Role of Mechanotransduction in Disease Pathogenesis

Summary
The ability of a cell to sense, integrate, and convert mechanical stimuli into biochemical
signals that result in intracellular changes is called mechanotransduction. Defects in
mechanotransduction are implicated in the pathogenesis of various diseases, including
arteriosclerosis, cardiomyopathies, asthma, and cancer. Thus, therapeutic means of
manipulating mechanotransduction to restore mechanical homeostasis in diseased
tissue represent a novel approach to treating various diseases. The goal of this R21
application is to develop a series of novel mechanotransduction-defective mouse strains
that the research community can apply to multiple diseases. Vinculin, a cytoskeletal
adaptor protein, plays a central role in sensing mechanical stress and mediating
structural remodeling and functional responses within the cell. Site-specific tyrosine
phosphorylation of vinculin has been proposed to regulate its mechanical role at both
cadherin and integrin adhesions. We hypothesize that vinculin phosphorylation
regulates the mechanical response of tissues to increase forces by adjusting the
balance between cell-cell and cell-extracellular matrix (ECM) adhesions. This R21
proposal seeks to develop and validate a series of point mutations that alter
posttranslational modification of vinculin in mice, thus allowing investigation of vinculin
mechanosensing in physiology and disease. The following interrelated aims are
proposed: (1) To test the hypothesis that tyrosine phosphorylation (Y822) of vinculin
coordinates the mechanical response of cell adhesion structures. (2) To test the
hypothesis that vinculin phosphorylation (Y100/Y1065) is required to facilitate cell-ECM
interactions. Due to the vast effects of mechanobiology on disease pathogenesis, our
innovative mouse models are anticipated to be widely used by scientists in an array of
fields and, therefore, of relevance to multiple NIH Institutes.

Public health relevance
Project Narrative: Understanding the impact of posttranslational modification on vinculin-mediated mechanotransduction may facilitate the design of novel therapeutic strategies to treat various diseases, including cancer and heart disease. The VCL phosphorylation-deficient mouse models proposed in this R21 application will allow the investigation of VCL mechanotransduction under physiological conditions for the first time. Due to the vast effects of mechanobiology in physiology and disease, our mouse models are anticipated to be widely used by scientists in various fields, with implications for multiple NIH Institutes.